Mapping epistatic interactions in molecular evolution of antibiotic resistance

PROJECT SUMMARY
Evolution of antibiotic resistance is a global public health problem. How evolution renders antibiotic
molecules ineffective by altering antibiotic targets is an interesting phenomenon from both clinical and basic
science perspectives. In pathogenic bacteria, there is only a handful of drug target enzymes such as DNA
gyrases, RNA polymerases, fatty acid synthetases, and enzymes involved in folic acid synthesis. Therefore, a
mechanistic understanding of resistance-conferring mutations in these enzymes is clinically critical for
designing new drugs or drug variants that can inhibit resistant bacteria.
In this project, we propose to study evolution of the Escherichia coli dihydrofolate reductase (DHFR)
enzyme and map epistatic interactions between DHFR mutations. DHFR is a ubiquitous enzyme with an
essential role in the folic acid synthesis pathway and is used as a drug target in antibacterial, anticancer, and
antimalarial therapies. In bacteria, an antibiotic named trimethoprim competitively binds to DHFR and blocks its
catalytic activity. Therefore, DHFR mutations that either confer resistance or compensate for reduced catalytic
activity of resistant DHFR mutants are selected for bacterial survival.
We will use laboratory evolution experiments to identify functional DHFR mutations and reproducible
genetic trajectories leading to elevated trimethoprim resistance. We will characterize these mutations by using
in vitro biochemical assays and deep-sequencing based fitness measurements for calculating epistatic
interactions between DHFR mutations. We will use molecular dynamics along with other computational tools
and nuclear magnetic resonance (NMR) spectroscopy to reveal structural changes responsible for resistance
and epistatic interactions. The combination of these approaches presents a unique opportunity to quantitatively
evaluate evolutionary paths leading to trimethoprim resistance and create a discovery pipeline for studying
protein evolution. By creating a deeper understanding for the evolutionary dynamics of an important drug target
enzyme, our proposal will develop experimental and computational tools for studying protein evolution with the
ultimate goal of improving human health. Indeed, our preliminary analyses suggest that we will be able to
design and test novel trimethoprim derivatives that can selectively inhibit DHFR mutants that carry the L28R
replacement, a common and synergistic DHFR mutation. We propose to synthesize trimethoprim-Dihydrofolate
hybrid molecules that will possess the salient structural features of both DHF and trimethoprim molecules
selectively inhibit DHFR mutants with the L28R replacement. We will evolve pan sensitive E. coli strains in the
morbidostat in order to quantify the efficacy of the mutant specific trimethoprim derivatives in impeding
resistance evolution and accordingly develop new strategies for better use of it.

Public health relevance
Project Narrative Understanding how mutations render antibiotics ineffective by modifying their targets is an important phenomenon from both clinical and basic science perspectives. In this project, we propose to study molecular constraints that drive evolution of trimethoprim resistance through mutations in the Escherichia coli dihydrofolate reductase (DHFR) enzyme. By creating a deeper understanding for the evolutionary dynamics of an important drug target enzyme, we will develop novel trimethoprim derivatives that can selectively inhibit DHFR mutants with the L28R, a frequently observed and synergistic DHFR mutation.